Computational methods for mechanistic understanding of inter-sample variability

DESCRIPTION: Computational methods for mechanistic understanding of inter-sample variability The overall goal of this R21 application is to develop a computational framework that will allow for the prediction of physiological differences between experimental samples. Differences between individual samples can be catalogued and described at the physiological level, in terms of properties such as action potentials, and also at the molecular level, in terms of measurements such as gene expression. Linking variability at one level to variability at another level in a quantitative manner, however, is not straightforward. Here, through an innovative combination of experimental studies, mathematical modeling, and statistical analyses, we will develop methods that allow for molecular-level differences between samples to be translated into quantitative predictions of physiological differences. This Multiple Principal Investigator proposal utilizes the complementary expertise of the two PIs. Dr. Eric Sobie is expert in cardiac physiology, mathematical modeling, and computational approaches for understanding variability~ Dr. Christoph Schaniel is expert in stem cell biology, differentiation of pluirpotent cells nto specific cell types, and high-throughput methods. The combined efforts of the two PIs will generate new quantitative data and will yield new computational methods that can be applied broadly to understand variability in different contexts. To achieve the overall project goals, we propose to: 1. Collect measurements of cardiac physiology and expression of relevant ion channels, pumps, and transporters. These measurements will be matched on a sample-by-sample basis. 2. Perform population-based simulations with dynamical mathematical models to develop quantitative and mechanistic predictions regarding how differences between samples in expression of important genes are translated into physiological differences. 3. Use regression-based statistical methods to analyze the experimental and simulation results, and to relate the two sets of predictions to each other. Not only is this exploratory research likely to provide insight into the physiology of cardiac myocytes derived from stem cells, it is also likely to demonstrate a novel computational framework that can be used for quantitative treatments of variability between samples in many biological contexts.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this project is to develop computational methods to that can be used to understand variability between individuals. Through a combination of experiments and mathematical modeling, we will develop methods that can be used to predict, for example, why some individuals respond to a particular treatment whereas others do not.